Neural Crest:New Perspectives on Lineage/Morphogenesis

DESCRIPTION (provided by applicant): The investigators are applying for funding to help support a small, topical and intense scientific meeting that they are organizing on the neural crest. The meeting will be held June 25-27, 2003 at a site on Mt. Hood, near Portland, Oregon. Nineteen speakers, a mixture of established world-class scientists and beginning investigators representing eight countries have been invited and have agreed to participate. There will be poster sessions and we expect the total size of the meeting to be about 150.